The Neuroprotective Role of PPAR-delta in Microglia

PROJECT SUMMARY/ABSTRACT
Alzheimer’s disease (AD) is a neurodegenerative disorder characterized by progressive memory loss
and cognitive impairment. AD leads to a significant reduction in quality of life, and with a rapidly growing
prevalence, there is a dire need for improved therapies. Peroxisome Proliferator-Activated Receptor delta
(PPARd) is a ligand activated transcription factor that has emerged as a potential target for neuroprotection.
PPARd agonism has been shown to improve disease phenotypes in neurodegenerative disease model mice,
and disruption of PPARd function in the central nervous system (CNS) of normal mice has been shown to elicit
neurodegeneration. PPARd agonism is also currently in a Phase 2a clinical trial for treatment of mild-to-moderate
AD. Of all the brain cells, microglia express PPARd most highly; however, the mechanistic basis of PPARd
activity in microglia remains undefined. Microglia are the resident immune cells of the CNS and have been
repeatedly implicated in the pathogenesis of AD, so understanding the role of PPARd in microglia will provide
insight into its therapeutic value.
Preliminary data reveals that PPARd can suppress inflammation in the brains of Huntington’s disease,
Parkinson’s disease and tauopathy model mice. Additionally, preliminary RNA-sequencing data on isolated
microglia from wild-type mice treated with the PPARd agonist KD3010 shows that PPARd agonism leads to
downregulation of inflammatory genes (e.g. Il-1b and SPP1) as well as the downregulation of several AD relevant
genes in microglia (e.g. C1QA/C1QB, IL12b and TYROBP). Microglia have been shown to take on aberrant
phenotypes in disease settings. These altered phenotypes have been shown to be cell-autonomous in human
induced pluripotent stem cell (iPSC)-derived microglia like cells (iMGLs) that harbor mutations relevant to AD.
For example, APOE4 microglia have been shown to exhibit reduced uptake of beta-amyloid, have shortened
processes, and have increased pro-inflammatory cytokine secretion. iMGLs are powerful models for human
microglia, as they are transcriptionally and phenotypically similar.
This proposal will uncover the mechanistic basis of PPARd function in microglia and interrogate whether
PPARd agonism can attenuate the aberrant phenotypes seen in microglia in the context of AD. I will first assess
whether PPARd transactivation of neuroprotective targets is dependent upon phase separation with the
transcriptional coactivator Mediator 1 and whether PU.1, which is a genetic risk factor for AD, interferes with
PPARd neuroprotection. I will then derive iMGLs from iPSCs that harbor an AD risk allele (APOE4) to assess
whether PPARd can attenuate the abnormal phenotypes, focusing on cytokine secretion and phagocytic
capacity. Understanding the role that PPARd plays in microglia and how its activation affects microglia in an AD-
relevant setting has the potential to provide further support as to why PPARd agonism should continue to be
pursued as a therapeutic for AD.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD) is the most common cause of cognitive decline and there remains no known cause of sporadic cases and no cure. The transcription factor PPARd has recently emerged as a promising disease- modifying therapy for AD and is currently the focus of a Phase 2a clinical trial for mild-to-moderate AD. In this proposal, I will evaluate the mechanism of PPARd neuroprotection in microglia and assess the value of PPARd as a therapeutic target for AD.